Interplay of bile acid and estrogen signaling

Hepatocellular carcinoma (HCC) is the sixth most common cancer worldwide and the third leading cause of
cancer-related deaths. At present, there are limited options in treating HCC patients. There are urgent needs to
develop effective therapies for HCC. Both farnesoid x receptor (FXR) and estrogen receptor  (ER) signaling
are linked to HCC. A large body of evidence support a view that FXR and ER signaling provide protection
against HCC development. FXR knockout (FXR-KO) mice spontaneously developed HCC as they aged while
ER-KO mice exhibited increased susceptibility to chemical-induced HCC. Consistent with their protective roles
in HCC, FXR and ER signaling were dysregulated or defective in large percentages (60-80%) of HCC patients
with decreased or total lack of FXR or ER expression with concurrent switches to its variants or different
isoforms. In our preliminary studies with FXR-KO, ER-KO and double FXR and ER knockout (FXR/ER-DKO)
mice, we discovered that FXR and ER signaling crosstalked each other through coordinately regulating a novel
oncogene ubiquitin specific peptidase 2 (USP2) in the development of HCC. The overall objective of this
proposal is to understand the interplay of FXR and ER signaling in HCC development and the underlying
mechanisms. The central hypothesis, built on our extensive preliminary results, is that FXR and ER signaling
have both tumor-protective and promoting activities dependent on the status of the other signaling through their
regulation of USP2 in a reciprocal antagonistic manner. Specific Aim 1 is to delineate the interplay of FXR and
ER signaling in HCC development. Specific Aim 2 is to determine the oncogenic roles of USP2 as a downstream
target of FXR and ER signaling in the development of HCC. Specific Aim 3 is to investigate the mechanistic
insights into the intriguing crosstalk between FXR and ER signaling in regulating USP2. The study represents
a pioneering effort to delineate the complex and interactive nature of FXR and ER signaling in HCC
development. The experiments proposed are built on our extensive, robust and novel preliminary findings as
well as our long-standing experience in studying FXR and ER signaling and their interaction in liver diseases
including cholestasis and HCC. With newly generated FXR/ER-DKO mice, our laboratory is thus uniquely
poised to investigate the interplay of FXR and ER signaling in HCC development. Implementation of these
innovative concepts and findings is expected to greatly enable the advancement of developing novel therapies
for HCC.

Public health relevance
Liver cancer is the sixth most common cancer worldwide and the third leading cause of cancer-related deaths. At present, there are limited options in treating patients with liver cancer. Bile acids and estrogens are two groups of signaling molecules that talk each other in controlling a variety of body functions including liver cancer. Dysfunction of the two signaling pathways has been directly linked to liver cancer. Understanding how the two signaling pathways interact each other at the molecular level will shed lights on uncovering novel targets or strategies to develop therapies for patients with liver cancer.